Core C: Neuroimaging Resource Core

CORE C: ABSTRACT
The Neuroimaging Resource Core (NRC; Core C) will provide support for Projects I and III of the University
of Michigan Udall Center by performing the acquisition, processing, and parametric analysis and interpretation
of all human subjects in vivo positron emission tomography (PET) and magnetic resonance imaging (MRI) data.
The specific goals of the NRC are:
1) To perform [11C]DTBZ vesicular monoaminergic transporter type-2 dopamine transporter and [18F]FEOBV
vesicular acetylcholine transporter PET on Parkinson disease (PD) subjects and age- and gender-matched
(NC) subjects at baseline and at follow-up.
2) To perform MRI, including T1- and T2-weighted, diffusion weighted (DWI), and resting state functional
connectivity (rs-fMRI) sequences on PD subjects and age- and gender-matched NC subjects at baseline and
at follow-up.
3) To perform parametric quantification of physiological parameters from the PET data for subsequent statistical
analysis in Projects I and III.
4) To perform parametric quantification of anatomical and functional parameters from the MRI data for
subsequent statistical analysis in Projects I and III.
5) Coordinate neuroimaging data transfer and analysis from the University of Groningen (the Netherlands)
Dutch Parkinson and Cognition (DUPARC) study.